Administrative Core

ABSTRACT
The support of our Administrative Core is essential to the integration of work on all projects and cores
including financial management, compliance with regulatory and reporting requirements, recruiting and
hiring, monitoring of employee performance and salaries and organization of activities that encourage
the sharing of information both within the Endocrine Unit and with other groups of Scientists with
similar interests.